Defining the mechanism of Shieldin complex in DNA end joining

Project Summary:
Human cells regularly acquire DNA double strand breaks (DSB) due to exogenous and endogenous chemicals
and as part of natural physiological processes (e.g. immune class switch recombination and meiotic crossover
events). Therefore, cells have evolved highly regulated DSB repair pathways which serve to protect from
particularly dangerous threats to genome integrity. It is for this reason that mutations in pathways responsible
for proper DSB recognition, processing, and resolution contribute to a variety of human diseases including
immune disorders, a variety of genetic syndromes, and cancer development. In general, cells have access to
two major pathways for DSB resolution, homologous recombination (HR) and non-homologous end joining
(NHEJ). A key regulator of DSB repair pathway choice is the 53BP1 protein which promotes NHEJ by blocking
extensive resection at a DSB which would favor HR. The Shieldin complex (composed of SHLD1, SHLD2,
SHLD3 & REV7) was recently identified as a downstream effector of 53BP1 signaling. Shieldin effects 53BP1’s
anti-HR functions by binding ssDNA overhangs at DSBs and blocking end resection. These observations lead
to the following conundrum: how can NHEJ, which prefers short overhangs or blunt DNA ends, be promoted by
a ssDNA binding complex? I propose to define the molecular mechanism underlying Shieldin function in DSB
repair using single-molecule (SM) imaging approaches. To this end, I will generate a panel of HaloTagged DNA
damage response (DDR) proteins using CRISPR/Cas9 mediated genome editing that will be used for SM live-
cell imaging. With these tagged proteins, I will dissect the regulatory mechanisms that control Shieldin
recruitment to DNA DSBs in vivo and define the molecular determinants for Shieldin binding at DSBs in vitro.
Generating a quantitative model of Shieldin function in regulating DSB repair will reveal the fundamental
mechanics of how Shieldin controls DSB repair pathway choice. As such, results from these studies will have
the potential for significant impact in the field as Shieldin’s role in DSB repair is incompletely understood.
Additionally, generating a quantitative model of Shieldin function could lead to the uncovering of novel
therapeutic approaches to target Shieldin function for clinical benefit.

Public health relevance
PROJECT NARRATIVE DNA double strand breaks (DSBs) are significant threats to genome integrity and stability. This project will reveal the fundamental mechanics of how a group of proteins known as the Shieldin complex participate in the repair of DNA DSBs via Non-Homologous End Joining which repairs most DSBs that occur within human cells. Using genome editing and single-molecule imaging approaches, I will establish a quantitative model for how the Shieldin complex functions in NHEJ which will provide a mechanistic basis for understanding how loss of this complex contributes to human diseases including cancer.